Lipid Peroxidation-Induced Mitochondrial Injury Inhibits Vascular Function in Single Ventricle Congenital Heart Disease

PROJECT SUMMARY/ABSTRACT
Over 50% of long-term survivors of the Fontan operation with single ventricle congenital heart disease develop
heart failure, for which standard therapies (ACE inhibitors, β-blockers) are largely ineffective. Thus, a major
challenge in treating Fontan heart/circulation failure is in understanding its unique mechanisms that differentiate
it from the more common acute ischemia-related heart failure and identifying new therapeutic targets. The
overarching goal of this proposal is to develop new therapeutic targets to preserve heart function, and to identify
biomarkers to detect heart/circulation failure earlier in the clinical course of patients with a Fontan circulation.
We have previously identified chronic oxidative stress-induced mitochondrial injury as a major mechanism in
Fontan failure. We hypothesize that oxidative stress induces cardiomyocytes to release damaged mitochondria
that impair endothelial function in both the heart (local) and peripheral vasculature (plasma) in patients with
Fontan failure. We examine this general question through the lens of cell-cell communication in the
cardiovascular system. In Aim 1, we will evaluate the role of chronic non-ischemic oxidative stress in causing
mitochondrial dysfunction in Fontan failure. We will use myocardial tissue to assess lipid peroxidation-induced
mitochondrial dysfunction, correlate mitochondrial dysfunction with severity of clinical illness and how damaged
mitochondria can be packaged and transported in extracellular vesicles to mediate cell-cell communication. In
Aim 2, we will investigate whether lipid peroxidation-induced mitochondrial injury impairs cardiac vascular
function. We will show that cardiac vascular dysfunction is a critical component of Fontan failure which may serve
as a novel therapeutic target. We will assess endothelial mitochondrial dynamics in myocardial tissue from
children with Fontan failure, assess cardiomyocyte and endothelial cell-cell communication via extracellular
vesicles and phenotype the cardiac microvascular tree to assess for lipid peroxidation and cell death. In Aim 3,
we will determine circulating biomarkers to monitor clinical status in children with and without Fontan failure and
compare to control. We will show that circulating extracellular vesicles carrying oxidatively damaged
mitochondria cause peripheral vascular endothelial dysfunction, determining the role of extracellular vesicles in
initiating metabolic reprogramming, both locally and in distant organs. Using innovative approaches, including
3D human tissue imaging and high throughput quantitative proteomics, in a large cohort of patients with a Fontan
circulation, we will test our hypothesis and examine the effectiveness of new mitochondrial-targeted therapies,
including repurposing the FDA-approved small molecule elamipretide to target lipid peroxidation. Through better
understanding of the unique mechanisms of Fontan failure, our team of clinicians and experts in mitochondrial
and vascular biology are poised to develop new strategies for preventing and treating cellular energetic failure
and vascular dysfunction.

Public health relevance
PROJECT NARRATIVE A major challenge in treating Fontan heart/circulation failure is in understanding the unique mechanisms of failure in these patients, since standard heart failure therapies are ineffective in this population. We have previously shown that mitochondrial injury plays a major role in this form of heart failure, and here will evaluate how mitochondrial injury in cardiac muscle cells leads to impaired function in cardiac blood vessel cells by cell-to-cell transport of damaged mitochondria. Through better understanding of the unique mechanisms of single ventricle heart failure we are poised to develop new strategies for prevention and treatment focused on cellular energetics and vascular dysfunction.